O-GlcNAc Modification in Metabolic Homeostasis

DESCRIPTION (provided by applicant): Metabolic syndrome is a result of the disturbance of metabolic homeostasis by complex interactions between genes and the environment. It has yet to be answered whether there is a unifying pathophysiology for metabolic syndrome. Investigators have looked into specific genetic and environmental factors involved in this medical condition. This reductionist approach may be ineffective to uncover the central mechanism(s) of the syndrome because metabolic homeostasis is a multifaceted and dynamic process. To this end, it would be critical to discover the molecular underpinnings that integrate systemic and dynamic variations in metabolism. Nutrient flux through the hexosamine biosynthetic pathway leads to the posttranslational modification of cytoplasmic and nuclear proteins by O-linked 2-N-acetylglucosamine (O-GlcNAc). This dynamic and reversible process involves two enzymes, O-GlcNAc transferase (OGT) and O-GlcNAcase (OGA), by which O-GlcNAc is attached to and removed from proteins, respectively. Growing evidence points to a pivotal role for O-GlcNAc in insulin signaling and metabolic regulation. Our recent work has shown that overexpression of either OGT or OGA in liver produces insulin resistance and dyslipidaemia. This surprising finding suggests that balanced O-GlcNAc levels are critical for metabolic homeostasis. Our central hypothesis is that O-GlcNAc serves as a key sensor and regulator of systemic homeostasis that links nutrient excess to metabolic syndrome. On the basis of our recent observation that O-GlcNAc is markedly disturbed in adipose tissue of mouse models of metabolic syndrome, we propose to investigate the contribution of O-GlcNAc in adipose tissue to the pathogenesis of metabolic syndrome and to delineate regulatory mechanisms for O-GlcNAc function in metabolism. We will accomplish these goals by executing the following Specific Aims: In Aim 1, we will determine changes in O-GlcNAc signaling in diet- and genetic-induced mouse models of metabolic syndrome. In Aim 2, we will test whether genetic intervention of O-GlcNAc in adipose tissue ameliorates metabolic defects in the mouse model of metabolic syndrome. Aim 3 will explore the regulation of OGT and OGA by posttranslational modifications. Understanding the impact of this regulatory switch on metabolic physiology shall lay a foundation for exploring O-GlcNAc as a therapeutic target for metabolic syndrome.

Public health relevance
PUBLIC HEALTH RELEVANCE: Metabolic syndrome affects at least 20% of the population in the United States, becoming one of the principal threats to human health in the twenty-first century. Completion of this proposal will establish the pathophysiological and mechanistic links between O-GlcNAc signaling and systemic metabolic homeostasis. Pharmacological intervention to reset O-GlcNAc levels may represent an innovative strategy for preventing and treating metabolic syndrome. Project Narrative Metabolic syndrome affects at least 20% of the population in the United States, becoming one of the principal threats to human health in the twenty-first century. Completion of this proposal will establish the pathophysiological and mechanistic links between O-GlcNAc signaling and systemic metabolic homeostasis. Pharmacological intervention to reset O-GlcNAc levels may represent an innovative strategy for preventing and treating metabolic syndrome. __SpecificAimsTextDelimiter__ SPECIFIC AIMS In modern societies across the globe, Western diet and sedentary lifestyle fuel a cluster of metabolic disorders including insulin resistance, abdominal obesity, atherogenic dyslipidemia, and hypertension. An individual with a collection of these risk factors, known as metabolic syndrome, is at increased incidence of type 2 diabetes and cardiovascular disease. Metabolic syndrome affects at least 20% of the population in the United States, becoming one of the principal threats to human health in the twenty-first century. Metabolic syndrome is a result of the disturbance of metabolic homeostasis by complex interactions between genes and the environment. Whether there is a unifying pathophysiology for metabolic syndrome has yet to be answered. Investigators have looked into specific genetic and environmental factors involved in this medical condition. This "reductionist" approach may be ineffective to uncover the central mechanism(s) of the syndrome because metabolic homeostasis is a multifaceted and dynamic process. To this end, it would be critical to discover the molecular underpinnings that integrate systemic and dynamic variations in metabolism. Nutrient flux through the hexosamine biosynthetic pathway leads to the posttranslational modification of cytoplasmic and nuclear proteins by O-linked β-N-acetylglucosamine (O-GlcNAc). This dynamic and reversible process involves two enzymes, O-GlcNAc transferase (OGT) and O-GlcNAcase (OGA), by which O-GlcNAc is attached to and removed from proteins, respectively. Growing evidence points to a pivotal role for O-GlcNAc in insulin signaling and metabolic regulation. Our recent work has shown that overexpression of either OGT or OGA in liver produces insulin resistance and dyslipidaemia. This surprising finding suggests that balanced O-GlcNAc levels are critical for metabolic homeostasis. Our central hypothesis is that O-GlcNAc serves as a key sensor and regulator of systemic homeostasis that links nutrient excess to metabolic syndrome. On the basis of our recent observation that O-GlcNAc is markedly disturbed in adipose tissue of mouse models of metabolic syndrome, we propose to investigate the contribution of O-GlcNAc in adipose tissue to the pathogenesis of metabolic syndrome and to delineate regulatory mechanisms for O-GlcNAc function in metabolism. The specific aims are as follows: Aim 1. To determine changes in O-GlcNAc signaling in diet- and genetic-induced mouse models of metabolic syndrome. Our preliminary results have demonstrated that O-GlcNAc levels are altered in mice fed high-fat diet (HFD) and db/db mice, supporting the physiological relevance of O-GlcNAc signaling to metabolic syndrome. We will determine the expression and activity of OGT and OGA in HFD and db/db mice. We will examine O-GlcNAc modification of the insulin signaling pathway in these mouse models. We will characterize the proteins whose O-GlcNAc modification is markedly altered in these mouse models. The completion of these studies will establish an O-GlcNAc signature of diabetic mouse models. Aim 2. To test whether genetic intervention of O-GlcNAc in adipose tissue ameliorates metabolic defects in the mouse model of metabolic syndrome. We have demonstrated that O-GlcNAc both in liver and in adipose tissue is markedly altered under diabetic conditions. It is known that resetting the O-GlcNAc level in liver can improve glucose homeostasis. We hypothesize that a balanced O-GlcNAc level in adipose tissue is also critical for systemic metabolic homeostasis. We will determine whether Cre-induced expression of OGT and OGA transgenes in adipose tissue predisposes normal mice to insulin resistance and dyslipidaemia. We will determine whether expression of OGT or OGA transgene in adipose tissue improve systemic insulin sensitivity and metabolic parameters in HFD mice. These studies will define the role of O-GlcNAc in adipose tissue in metabolic homeostasis and lay a foundation for exploring O-GlcNAc as a therapeutic target for metabolic syndrome. Aim 3. To explore the regulation of OGT and OGA by posttranslational modifications. O-GlcNAc modification of target proteins is highly dynamic and cyclic in response to nutritional and hormonal signals. OGT and OGA activity must be precisely regulated to prevent a futile cycle and elicit functional outputs. We hypothesize that posttranslational modifications of OGT/OGA themselves are a central mechanism by which O-GlcNAc acts as a sensor and regulator of metabolic homeostasis. We will identify potential sites of posttranslational modifications on OGT and OGA by mass spectrometry. By mutational analysis we will assess the effects of identified posttranslational modifications on OGT/OGA enzymatic activity, stability, and subcellular localization. We will determine whether OGT and OGA are mutually regulated. The accomplishment of these aims will not only establish a causal link between O-GlcNAc and systemic nutrient homeostasis in the pathophysiological settings, but also provide critical insight into regulatory mechanisms underlying O-GlcNAc signaling. Pharmacological intervention to reset O-GlcNAc levels may represent an innovative strategy for preventing and treating metabolic syndrome.